Mechanism of Intracellular ANGPTL3 and ANGPTL8 Trafficking

Abstract
Lipids circulate in the blood in lipoproteins including chylomicrons and very low-density lipoproteins (VLDLs).
Lipoprotein Lipase (LPL) is the main enzyme that hydrolyzes the triglycerides from circulating lipoproteins into
free fatty acids that can be taken up by cells. Without LPL, dangerously high levels of lipoproteins circulate in
the blood, which can lead to cardiovascular disease, amongst other diseases. LPL inhibitors, known as
angiopoietin-like (ANGPTL) proteins have key roles in the regulation of lipid metabolism. ANGPTL3 is a potent
inhibitor of LPL. ANGPTL8 can form a complex with ANGPTL3 which results in even greater inhibition of LPL.
ANGPTL8 is only found in the bloodstream in complex with ANGPTL3. However, where this complex forms, and
why ANGPTL8 requires ANGPTL3 for secretion remains a mystery. This proposal aims to understand why
ANGPTL8 is unstable when it is not in a complex with ANGPTL3, as well as visualizing the ANGPTL3/8 complex
trafficking dynamics.

Public health relevance
Project Narrative High levels of blood triglycerides are a risk factor for cardiovascular disease in humans, so new ways to manage blood triglycerides are needed. Lipoprotein lipase (LPL) is an essential enzyme for the clearance of triglycerides from the blood. This project aims to determine the trafficking pathways and subcellular localization of two LPL inhibitors, angiopoietin-like (ANGPTL) protein 3 and ANGPTL8, which could lead to ways to boost the activity of LPL by blocking its inhibition.